Discovery and Mechanism of Biosynthetic Enzymes

PROJECT SUMMARY
Biosynthetic pathways are rich in enzymatic transformations that produce structurally
diverse natural products, such as secondary metabolites, modified nucleic acids, and
modified peptides. Discovering and understanding the molecular basis for these
transformations underpins efforts towards development of deep insights into factors that
either belie many disease processes, or their use in development of therapeutic agents.
The two major NIGMS-funded research areas in the Bandarian lab at the University of
Utah focus on (1) discovering the molecular basis of biogenesis of the pyrrolopyrimidine
core structure found in a variety of secondary metabolites, as well as in the hypermodified
base, queuosine, and (2) elucidating the mechanism of enzymes involved in the
biosynthetic pathways of ribosomally synthesized posttranscriptionally modified
polypeptides (RiPPs), which are emerging as a new group of natural products with
substantial potential as therapeutic agents. These pathways often utilize complex radical-
mediated enzymatic transformations whose mechanisms are not known. The discovery
and mechanistic studies of these enzymes are proposed as part of this R35 application.
!

Public health relevance
PROJECT NARRATIVE All organisms produce a bevy of small molecules, many of which are not required for primary metabolic processes but confer selective advantage to the producing organism in complex biological environments. The biosynthetic pathways to these molecules often involve complex enzymatic transformations, which in many cases remain to be discovered. Understanding the biosynthetic pathways to these small molecule natural products is an important step in gleaning their role in physiology, with an ultimate goal of introducing them in the clinic.! !